Understanding omega-3 and 6 fatty acid dependent regulation of inflammatory signals in pancreatic cancer

PROJECT SUMMARY
Pancreatic ductal adenocarcinoma (PDAC) is a highly lethal cancer with a five-year survival rate of just over
10%. Its incidence is rising and is projected to become the second leading cause of cancer deaths by 2030, with
obesity increasing risk by 20-50%. Obesity induces chronic inflammation, and inflammation has been found to
be essential in driving PDAC, as KRAS mutations alone cannot initiate tumorigenesis without an inflammatory
trigger. Normally, inflammation aids wound healing by stimulating the next phase of tissue regeneration, but
unresolved chronic inflammation leads to sustained cell proliferation and fibrosis, which drives cancer
progression. Understanding how to resolve inflammation and restore tissue homeostasis is key to preventing
chronic inflammation and progression to PDAC.
A hallmark of wound resolution is lipid-mediator class-switching, where cells shift from producing pro-
inflammatory signaling lipids to those promoting resolution. These bioactive lipids arise from omega-3 (n-3) and
omega-6 (n-6) polyunsaturated fatty acids (PUFAs). Typical n-6 PUFAs such as linoleic acid (LA) and
arachidonic acid (AA) are metabolized into pro-inflammatory mediators like leukotrienes and prostaglandins.
Typical n-3 PUFAs, such as eicosapentaenoic acid (EPA) and docosahexaenoic acid (DHA), are converted into
anti-inflammatory specialized pro-resolution mediators (SPMs) like resolvins, protectins, and maresins. Both
‘upstream’ n-3 PUFA signaling and ‘downstream’ SPM signaling suppress inflammation and aid healing. Dietary
fish oil, rich in n-3 PUFAs, is linked to reduced pancreatic tumorigenesis, though mechanisms remain unclear.
Our preliminary data support the central hypothesis that dietary n-3 PUFAs promote lipid class-switching,
reduce inflammation and slow PDAC progression, but the pathways involved require further investigation.
Comparisons of the PDAC tumor microenvironment (TME) between mice fed n-6 and n-3 high fat diets (HFDs)
show that many inflammatory cytokines and IL-6 family members decrease, while 18-HEPE and 17-HDoHE,
resolvin precursors, accumulate in tumors from n-3 fed mice. Tumor-associated macrophages (TAMs) mediate
this lipid switching, with n-3 PUFAs enhancing MHC-II and Cxcl16 expression while reducing Il6, Lif, and
Arginase1 levels. This suggests that n-3 PUFA metabolism reshapes TAM function and metabolism to suppress
tumor growth. To clarify the underlying mechanisms of action of n-3 PUFAs in PDAC, we will examine: 1) which
cells drive tumor repression by n-3 PUFA production, 2) how signaling through GPR120 and SPMs suppress
PDAC, 3) how shifts in macrophage states limit PDAC by inhibiting IL-6-family members or increasing MHC-II-
CD4 T cell interactions, and 4) how n-3 PUFAs affect epigenetic remodeling and ‘inflammatory memory’ in
macrophages, fibroblasts, and tumor cells. This study will uncover key signaling, metabolic, and epigenetic
mechanisms by which dietary lipids reduce inflammation and prevent cancer.

Public health relevance
NARRATIVE Pancreatic ductal adenocarcinoma (PDAC), a highly lethal disease with a five-year survival rate of just over 10%, is expected to become the second leading cause of cancer-related deaths by 2030. Though early studies have linked the consumption of dietary fish oil, which is high in omega-3 (n-3) polyunsaturated fatty acids (PUFAs), to significantly reduced pancreatic tumorigenesis, the precise mechanisms by which n-3 fatty acids control tumor growth remain unclear. The proposed research will test the concept that inducing an anti-inflammatory, pro- resolving state through dietary n-3 PUFAs can actively suppress the tumor-promoting effects of inflammation and elucidate the underlying mechanisms governing how n-3 vs. n-6 lipids either facilitate or restrict tumor progression.